Development of safe harbor CRISPR inhibition and activation tools for systematic biological inquiry in zebrafish

Summary – We will establish and validate stable system for CRISPR interference (CRISPRi) and CRISPR
activation (CRISPRa) in zebrafish, employing attP safe harbor PhiC31 integration sites. The application of
CRISPRi and CRISPRa technologies in zebrafish has the potential to expand its capacity for the study of gene
function significantly. It will afford the modulation of promoters and regulatory sequences alike, facilitating
efficient loss of function and gain of function evaluation of biological and pathological relevance. We recently
developed codon-optimized CRISPRi/a constructs for zebrafish, establishing their function in proof-of-principle
experiments, using RNA injection of system components to modulate key genes in established phenotypes.
We synthesized a zebrafish codon-optimized cas9 gene, harboring mutations D10A and D839A to render
the protein catalytically inactive (dCas9). We then cloned codon-optimized Krüppel associated box (KRAB) and
methylated CP2 (MeCP2) inactivating domains or VP64 activator domain downstream from dCas9 for CRISPRi
and CRISPRa, respectively. To validate the biological function of our initial CRISPRi construct, we targeted the
promoter sequences of key genes in melanocyte differentiation (sox10, mitfa, and mitfb); and melanin production
(tyrosinase; tyr). Microinjection of CRISPRi mRNA with single guide RNAs (sgRNAs) targeting their promoters
resulted in hypopigmented larvae (epidermal melanocytes and retinal pigmented epithelium. In addition, we
evaluated CRISPRi/a modulation of mrap2a, which controls energy homeostasis and somatic growth via
inhibition of the melanocortin 4 receptor gene (mc4r). Targeting the mrap2a promoter proximal region with
CRISPRa or CRISPRi increases and decreases larval body length, respectively. However, RNA-based injections
inherently display time-limited effects whose impact is unreliable beyond the development.
Thus, here we propose to establish transgenic lines, stably expressing CRISPRi and CRISPRa from
constructs integrated into attP safe harbor integration sites in chromosome 14 facilitated by the PhiC31 integrase
(Aim 1). We will screen the efficacy of these new lines via Tol2-mediated delivery of sgRNA expression
constructs directed at known genes whose modulation yield readily scored phenotypes, as above. Similarly, we
will establish and validate constructs for efficient delivery of sgRNA expression to an alternate attP PhiC31 site
in chromosome 24 (Aim2). The lines expressing CRISPRi/CRISPRa will be crossed with the empty alternate
PhiC31 site, allowing the use of the second site for targeted integration of sgRNA expression constructs. The
establishment of lines established in Aims 1 and 2 will be confirmed by the inclusion of discrete reporter cassettes
expressing Cerulean [blue, Aim 1] and Venus [yellow, Aim 2] in the pineal and the lens of the eye, respectively.
The efficiency of lines generated in aim 2 will be evaluated using guides designed to the promoters of genes
employed in Aim 1 validation. Robust CRISPRi and CRISPRa systems in zebrafish will facilitate efficient assay
of candidate gene function and disease relevance through bidirectional modulation of gene expression.

Public health relevance
The shared biology between human and zebrafish has facilitated the establishment of this fish as a powerful model system in which to functional explore the function of genes implicated in disease and the sequences that control their timing and location of activities. The development of new CRISPR genome engineering technologies allow the upward and downward tuning of gene activities in mammalian systems but have not yet been fully implemented in zebrafish. We will develop a new system for zebrafish in which this kind of gene function modulation is rendered systematic and straightforward and we support our proposal with key proof of principle data.